Mapping Individual Cognitive Differences to Neural Variance and School Readiness

DESCRIPTION (provided by applicant): The early school age period is a time of significant developmental change in both cognitive abilities and neural systems. Yet little is known about how, specifically, these developmental processes that occur concurrently are linked to each other, or about the nature of critical interactions of biological factors with childhood experiences and environments. The proposed project takes a critical first step in addressing this problem by examining, in unprecedented detail, the development of basic cognitive processes and of the neural systems that mediate them during the child's transition to formal schooling. The design is a longitudinal study of 100 typically- developing children inducted at age 6 and assessed with behavioral measures and MRI annually on 5 occasions. The behavioral measures to be collected, of language, visuospatial processing, working memory, and cognitive control, have exhibited high sensitivity to developmental change over this age range. MR imaging of the children will involve recently developed, improved methods for image acquisition and computational modeling of the results. Diffusion parameters from specific brain fiber tracts as well as regional measures of cortical surface area and thickness will be measured. The focus of the study is on differences in the rate of fiber tract development from 6 to 10 years of age and links between this variability and the pace of cognitive development. Relationships between the neural parameters and early academic achievement will also be examined. The study is novel, not only because the imaging methods to be applied will produce more detailed information about the brains of children than is currently available, but also because of the conceptual focus of the project on the degree of concordance between trajectories of brain and behavioral development. The long-term significance of the study lies in its potential to guide us toward interventions that are more adaptive to individual differences and therefore promote positive outcomes in more children.

Public health relevance
PUBLIC HEALTH RELEVANCE: The research described in this application will use magnetic resonance imaging to determine how much healthy children differ from each other in the rate at which their brains develop biologically, particularly in the connecting fibers that transmit information within the brain, and how closely this mirrors the pace of their mental development. The aim of the research is to increase our understanding of differences among children so that we can use this knowledge to create more supportive environments for all children, and also to guide us toward interventions that may allow us to prevent some mental illnesses. Project Narrative The research described in this application will use magnetic resonance imaging to determine how much healthy children differ from each other in the rate at which their brains develop biologically, particularly in the connecting fibers that transmit information within the brain, and how closely this mirrors the pace of their mental development. The aim of the research is to increase our understanding of differences among children so that we can use this knowledge to create more supportive environments for all children, and also to guide us toward interventions that may allow us to prevent some mental illnesses. __SpecificAimsTextDelimiter__ Specific Aims Over the past three decades, research in developmental neurobiology has changed the way we think about mammalian brain development. Previously, the relationship between brain and behavioral development was viewed as unidirectional; brain maturation was thought to enable behavioral development. Modern neurobiological methods have revealed that it is the interaction of genetic factors and the experience of the individual that guides and directs brain development1. Brains do not develop normally in the absence of critical genetic signals, and they do not develop normally in the absence of essential environmental input. These fundamental facts about brain development are important for understanding the relationship between brain and behavioral development in children. Human brain development is a protracted process, beginning in the third week of gestation and continuing into early adulthood. During the early school-age years, ongoing maturation in the brain's connecting fiber tracts is particularly striking2. Age-related changes on brain MRI have been described in normative samples of children2,3. These studies focus on the modal course of brain and behavioral development, and on delimiting the range of normal neurocognitive trajectories4. As the data accumulate, they will provide benchmarks for assessing developmental milestones, and may improve detection of pathology. However, an equally important, but understudied, set of questions concern individual differences in the cognitive abilities and profiles of typically developing children. The biological inheritance and experiences of each child are unique. These differences have consequences for how the brain develops and, reciprocally, for the development of new skills and abilities. Though individual differences in cognitive development have been studied before, until recently evidence regarding related neurobiological changes in developing children has been very limited; and few studies have linked trajectories of cognitive development to those of neural development directly. Indeed, innovations in neuroimaging technology have only recently made it possible to use structural imaging techniques to examine relevant architectural features of the brain in sufficient detail. In the proposed study, 100 children inducted at age 6 will be followed annually for 5 years to assess brain maturation and cognitive abilities. Basic cognitive functions will be assessed in four domains: language, working memory, visuospatial processing, and cognitive control (response inhibition); and, in addition, early academic achievement in reading, writing, and mathematics will be assessed. The primary focus will be on linking the now well-established developmental alterations in brain fiber tracts to developing cognitive functions. However in secondary analyses we will also examine associations between cognitive development and two other neural architectural features: cortical thickness and surface area; and we will explore the educational implications of observed associations by describing links to early academic achievement. Conceptually, the focus is on explaining variability in cognitive abilities among young children of similar age. A central question is whether a significant component of this variability is statistically attributable to variability in the rate of biological development of brain connectivity. In previous studies FA has been linked to brain development, to fiber tract coherence and fiber density, and to performance variability, in both children and adults (as reviewed below). Correlations between fiber tract structure and cognitive abilities in children of the same age could arise from variability among children in the pace of white matter maturation; but alternatively, or in addition, these effects could arise from differences among children in the underlying architecture of structural connections - differences that may be relatively unrelated to the phase of brain maturation. Thus important questions remain about the nature of the association between cognitive abilities and fiber tract structure in children. Answers to these questions are needed for a deeper understanding of behavioral phenotypic variability and for guiding improvements in educational methods and pediatric interventions for behavioral disorders. Since these questions are fundamentally about trajectories of development, they require a longitudinal approach and a multivariate modeling strategy. The major aims of this longitudinal study therefore are: 1) To test a set of specific hypotheses about links between developing brain connectivity and performance on cognitive and academic tasks. 2) To address the lack of existing longitudinal data that permit comparisons of neural with behavioral trajectories from children in the 6-10 year age-range when children enter formal education. 3) To apply novel imaging and computational methods with better sensitivity and anatomical specificity than those applied in previous studies. 4) To explore the implications of individual differences in brain connectivity and developmental trajectories for the emerging academic skills of children.